Exposure Core

PROJECT SUMMARY – Exposure Core
A robust exposure assessment is key to the success of any environmental epidemiology or toxicology project
and determining exposure can be complex as people are exposed to multiple compounds through multiple
exposure pathways. During the initial funding period, the Exposure Core has become a well-known hub on
campus for seeking advice on the exposure related portion of study design and for developing new and helpful
methods and facilities to further environmental health research. The Exposure Core has helped connect
investigators with analytical laboratories that can help further their exposure characterization, assisted
epidemiologists with robust exposure assessment design, and aided toxicologists to quantify exposures and
relate them to a relevant benchmark or tissue level. For multi-chemical scenarios, The Core has helped ensure
that laboratory exposures model real-world human exposure scenarios. The overarching goal of the Exposure
Core is to provide comprehensive exposure study design and analysis expertise to improve the quality of
studies that require exposure assessment for epidemiological studies and exposure environments for
toxicological studies, and hence improve the quality of environmental health research conducted at UC Davis.
Exposure Core laboratories include expertise in: 1) target and non-target analysis of organic compounds in
environmental and biological samples, 2) time-integrated or time-window specific exposure concentrations, 3)
compositional analysis of environmental samples to identify organic functionality via FTIR and mass
spectrometry and elements and isotopes via XRF and ICPMS analysis, 4) design guidance for animal
inhalation toxicology studies from a range of air pollutants and sources, 5) resources for helping environmental
justice communities determine potential exposures, an exposure vivarium for traffic related airborne particles,
and 5) a portable wildfire measurement system. Core members continue to expand the capabilities of their labs
to meet these growing needs of center members. The core is increasing our capabilities in helping faculty
working with community groups to evaluate compounds of concern and develop streamlined methods for
evaluating community exposures. The Exposure Core has developed a program to provide seed funding to
investigators for method development to build capabilities. The Exposure Core also provides both subsidies
and seed funding for sample analysis in the core laboratories for center members. We provide advice on the
study design through Specific Aims Reviews hosted by the Administrative Core, through Exposure Design
Reviews for potential pilot applicants, and through meetings with investigators. By providing exposure
assessment expertise to investigators as part of an integrated core, rather than via independent campus
laboratories, we will be able to provide a much more robust, appropriate, and custom tailored exposure
assessment through our synergies, interactions and collaborations.